Brain-selective estrogen therapy for menopausal hot flushes in an advanced translational animal model

ABSTRACT
Menopause is an inevitable stage in normal human aging, affecting the quality of life of millions of women all
over the world. Menopausal symptoms including hot flushes, sleep disorders, depression/anxiety, decline in
cognitive function (Alzheimer’s disease is more prevalent in women and linked to estrogen), cardiovascular
disease, genitourinary conditions, and osteoporosis. These symptoms have been shown to be causally linked to
a sharp decline in circulating sex steroid concentrations after menopause. While men have similar decline in sex
hormones, andropause symptoms are usually infrequent and mild. Consequently, menopausal symptoms are of
considerably more pressing medical concern in elderly women than andropause in elderly men. Thus, this
proposal focuses on women’s health and improved therapies for menopause.
The most immediate and patient reported ‘unbearable’ symptom of the menopause are hot flushes, which
cause not only physical discomfort but also negatively impact mood, behavior and general quality of life. Among
current treatments of hot flushes, only estrogen therapy (ET) and hormone therapy (HT, estrogens and
progestins) have satisfactory efficacy. Although ET/HT prevents hot flushes, they have unwanted side effects in
the periphery, including the stimulation of the uterus and breast leading to a significantly increased cancer risk
in these organs. Although there have been extensive efforts to develop safer estrogens, the lack of animal
model(s) that naturally recapitulate the symptoms and pathophysiology of human menopause has had a
tremendous negative impact on the success of this effort. Only humans and our close mammalian cousins exhibit
menopausal hot flush symptoms in normal aging or with ovariectomy. However, the most commonly utilized
model for thermoregulation is rodent, which is limited for translational drug discovery with human menopause as
rodents do not normally flush and do not sweat.
We developed an old-world advanced translational animal model which undergoes a menopausal process that
is hormonally identical to that of human women. We show that ovariectomy induces hot flushes that are
exacerbated by niacin and nearly eliminated by estrogen therapy. This also involved development of novel use
of non-invasive thermal imaging to detect these events, alleviating the need for older train-and-restrain models
used in this species for hot flush research in the past. Using this model, we propose to test a novel estrogen
prodrug therapy using 10β,17β-dihydroxyestra-1,4-dien-3-one (DHED). DHED has ideal properties for a
translational therapy for hot flushes. In the prodrug form it is highly shelf-stable at room temperature, can be
taken orally, has no peripheral bioactive properties in the prodrug form and it is selectively converted to estrogen
only in the brain, resulting in no peripheral side effects on uterus/breast. We propose a comprehensive testing
of the pharmacological effectiveness of DHED to treat hot flushes in our advanced translational model as a key
step to human clinical trials.

Public health relevance
NARRATIVE Despite the high in incidence of deleterious symptoms associated with menopause in women, the only effective treatment to block these symptoms remains estrogen-based therapies which carry significantly elevated risks of breast/uterus cancer in patients on these therapies. There is a critical need to have a safer alternative to estrogen therapy to alleviate the menopausal symptoms, hot flushes in particular, without the peripheral side-effects. This advanced translational project test if the novel prodrug DHED, which is biologically inert in the periphery but converted to estrogen selectively and only in the brain, can prevent hot flushes while having no peripheral effects on breast/uterus.